Interoception as a Novel Risk Factor for Suicidal Thoughts and Behaviors

Project Summary
Suicide is a leading cause of death worldwide and the second leading cause of death for adolescents in the
US. Despite advances in understanding of suicidal thoughts and behaviors and their treatment, the suicide rate
has not decreased. One possible factor limiting progress in this area has been a lack of focus on
understanding (and targeting) developmental mechanisms that may give rise to suicidal thoughts and
behaviors. Interoception, the perception of internal bodily states, holds promise as a novel factor that may
increase risk for suicide. Suicidal thoughts and behaviors center around inflicting harm to the body, yet
surprisingly little work has tested whether and how disrupted interoceptive processes may contribute to risk for
suicide. Given the centrality of the body in suicidal thoughts and behaviors and the unique interoceptive
learning and processing that may occur during adolescence, altered interoceptive processing represents a
novel risk factor that may advance understanding of suicidal thoughts and behaviors among adolescents. This
proposal tests the associations between interoceptive processes and the occurrence of suicidal thoughts and
behaviors. Eighty adolescents with and without suicidal thoughts and behaviors will undergo assessments of
suicidal thoughts and behaviors, psychophysiological measurement of interoceptive processes, exposure to
childhood trauma, and ecological momentary assessments of suicidal thoughts and behaviors and appraisals
of body sensations. Aim 1 of this proposal is to test the association between perceptual interoceptive
processes (i.e., interoceptive accuracy, sensitivity, and attention) and suicidal thoughts and behaviors. Aim 2 of
this proposal is to test the association between appraisals and descriptions of body sensations and suicidal
thoughts and behaviors. Aim 3 of this proposal is to test whether interoceptive processes are a potential
mediator of the associations between childhood trauma and suicidal thoughts and behaviors. The proposed
study’s greatest potential impacts are to use innovative strategies to study a novel potential risk factor for
suicidal thoughts and behaviors, identify putative pathways that have clear translational value, and to
potentially identify novel targets for intervention to treat suicidal thoughts and behaviors in adolescents.

Public health relevance
Project Narrative Suicide claims more than forty thousand lives in the United States each year, making it a leading cause of death, the 2nd leading cause of death for adolescents, and a devastating public health concern. The goal of this project is to test the associations between interoceptive processes and the occurrence of STBs during adolescence, using innovative, rigorous methods such as ecological momentary assessment, hospital-based data collection, and advanced statistical modeling. Results can provide an enhanced understanding of suicidal thoughts and behaviors in adolescents, which can provide crucial insight to improve understanding of suicide in adolescence, as well as novel targets for clinical intervention and suicide prevention.